Dynamic retinal coding in natural environments

Project Summary
Natural environments present numerous challenges to the visual system, including the presence
of large and frequent changes in light intensity. Such changes occur when an animal moves from
sunlight into shadow, or when it shifts its gaze from a bright to a darker area in a scene (e.g., sky
versus shaded ground). These changes can occur frequently, e.g. many times per minute, and
the intensity changes can be as large as 50-100-fold. These sudden, frequent, and large changes
in light intensity present a challenge to the retina, which must transmit a reliable visual signal as
it dynamically adapts to the new intensity: this adaptation is likely to be only partial, because the
intensity is likely to change again within the next few seconds. Furthermore, adaptation
mechanisms triggered by these changes in light intensity alter the spatial and temporal integration
of retinal ganglion cell (RGC) receptive fields, which is tantamount to changing the neural code
sent to downstream brain circuits. How can reliable visual signaling be achieved when the code
is in perpetual flux? These dynamic lighting conditions differ substantially from those typically
probed in laboratory experiments, where the mean and contrast of stimuli are often held
approximately constant. The overarching goal of this proposal is to understand how naturalistic
dynamic intensity conditions impact retinal function and visual signaling. We hypothesize that by
examining retinal coding under these dynamic intensity conditions, we will learn how diverse
adaptation mechanisms work in concert across multiple cell types to provide a reliable signal to
downstream brain areas in natural environments. This work is significant because it will advance
our understanding of how the visual system copes with rapid and naturalistic changes in light
intensity. Aim 1 will determine the role of adaptation in phototransduction in shaping RGC
responses. Aim 2 will probe the contribution of RGC spike generation. And Aim 3 will determine
the impact of adaptation in intermediate circuitry, with a focus on the role of AII amacrine cells.
These mechanisms will be linked using a CNN-based framework that permits study not only of
how the individual mechanisms work, but how they interact and collectively shape RGC
responses. These aims will reveal how adaptation in distinct loci of retinal processing
(photoreceptors, interneurons and RGCs) shape the encoding of visual features in dynamic
environments. Furthermore, they will reveal how key RGC types in the primate and rodent visual
systems deal with naturalistic fluctuations in light intensity as they visually scan and move through
the environment.

Public health relevance
Project Narrative Retinal degenerative diseases frequently cause failures in adaptation to changes in the statistics of visual input such as changes in the mean light level. The work proposed here aims to understand how visual adaptation operates under naturalistic stimulus conditions. This is likely to provide new insights into the diagnosis and treatment of disorders of the visual system and retinal degenerative diseases.